Regulators of Immune Complex Mediated Neutrophil Recruitment and Tissue Injury

ABSTRACT Antibody-antigen complex (IC) deposition within and outside blood vessels that is associated with neutrophil infiltration is pathogenic in many human immune mediated disorders. The objective of this competing renewal remains the delineation of receptors and intracellular signals that regulate IC-mediated neutrophil recruitment and associated organ damage. FcγRs have emerged as key mediators of inflammation in a range of IgG-mediated diseases from glomerulonephritis, arthritis and vasculitis to fatal anaphylaxis. Our studies in mice expressing the uniquely human activating FcγR, FcγRIIA selectively on neutrophils of mice lacking their own activating FcγRs have shown that FcγRIIA is a key molecular link between IC deposition, neutrophil influx and tissue damage. As such, this receptor must be tightly controlled. In the last funding cycle, we identified two major pathways regulating FcγRIIA function. First, surprisingly, the neutrophil CD18 integrin Mac-1, known to promote inflammation, inhibited FcγRIIA mediated neutrophil capture by immobilized ICs under flow by cis interaction of its ligand binding domain with FcγRIIA's ectodomain. This may have relevance for human disease as the non-synonymous Mac-1 small nucleotide polymorphism (SNP) R77H associated with lupus and systemic sclerosis risk impaired Mac-1's affinity for its known ligand, complement C3 and for FcγRIIA. Second, we showed that FcγRIIA signaling to Abl-1/Src kinase and subsequent F-actin polymerization was required for rapid neutrophil arrest on IgG and the strengthening of FcγRIIA-IgG bonds under shear flow in vitro. Accordingly, in vivo, 2- photon intravital microscopy (IVM) of the kidney revealed that in glomerular capillaries, intravascular ICs directly captured neutrophils via their FcγRIIA without evidence of prior neutrophil rolling. This recruitment was inhibited by a Abl/Src inhibitor suggesting that it is an active process requiring intracellular signaling. Two related questions arise from these findings that are the basis of the current proposal. First, how is the interaction of FcγRIIA-Mac-1 ectodomains regulated, does R77H perturb this interaction and how does this lateral interaction inhibit FcγRIIA affinity for ligand? Second, what FcγRIIA mediated intracellular pathways are engaged to promote capture of circulating neutrophils by deposited IgG? These questions will be addressed using knock-out mice, IVM and models of disease combined with fluorescent lifetime imaging microscopy (FLIM) analysis, biochemical assays and in vitro assays that mimic neutrophil recruitment to IC-coated endothelial cells under flow. We anticipate that the information provided by the proposed studies will give insights into how FcγRIIA mediated neutrophil recruitment is regulated and thus identify important therapeutic leads for the prevention of FcγRIIA mediated neutrophil accumulation, potentially one of the earliest events in IgG mediated inflammatory disorders.

Public health relevance
NARRATIVE Neutrophils initiate organ damage in many autoimmune diseases. We have shown that IgG antibody deposition within blood vessels triggers rapid neutrophil capture via their IgG receptor, FcγRIIA, suggesting that FcγRIIA is a key link between IgG deposition and organ damage. Our proposed work will provide insights into how FcγRIIA's activity is regulated and thus identify therapeutic leads for preventing IgG- mediated neutrophil influx and subsequent organ damage in antibody-mediated inflammatory disorders.